Outcomes study for the XL1 distraction enterogenesis device to improve nutrient absorption in short bowel syndrome patients

PROJECT SUMMARY
Short Bowel Syndrome (SBS) is a rare and devastating condition where patients are unable to absorb enough
nutrients naturally to sustain life. SBS results when certain diseases or conditions that destroy the small intestine
force the loss and surgical removal of the majority of the small intestine. In the pediatric patient population, the
most common diseases that lead to SBS are necrotizing enterocolitis, midgut volvulus, and intestinal atresia. In
the adult population, diseases include Crohn’s, cancer, intestinal ischemia, and trauma. Whatever its cause,
SBS leaves the patient without enough functional small intestine to absorb nutrients from the food they consume.
Current chronic therapies for SBS include parenteral (intravenous) nutrition, daily medication, and intestinal
surgery. None of these treatments restore natural absorption of nutrients, and they are associated with significant
complications and costs. Complications from daily parenteral nutrition include liver failure and central line infec-
tions (sepsis), and mortality rates as high as 30% by age 5 have been reported. Current treatments are also
staggeringly costly: the average 5-year cost has been estimated at $1.6M per patient. For pediatric patients, the
costs of treatment can exceed $500,000 in the first year, and they may require treatment their entire lives. Hence,
there is an urgent need for a novel treatment that can offer SBS patients a cure.
Clinical studies have shown that for every additional 1% of residual small bowel a child possesses, the odds
of weaning from parenteral nutrition increases by 3%. Over the last decade, intestinal lengthening, via a process
called distraction enterogenesis––stretching the intestine to force it to grow, has emerged as a potential restor-
ative treatment option that can help SBS patients grow new small intestine.
Eclipse has been developing a novel mechanical device––the Eclipse XL1 System for Distraction Entero-
genesis––that can stimulate the growth of healthy small intestine tissue. The XL1 device is currently in a phased
safety study before Eclipse begins a probable benefit (HDE) study to support an application for approval as a
Humanitarian Use Device.
The proposed project will support the probable benefit phase of the study. It will enable Eclipse to treat
patients at existing trial sites (Cincinnati Children's Hospital and Boston Children's Hospital; participated in the
safety phase) to get to the projected halfway point of the probable benefit study in the first year. It will allow the
trial to expand to two new study sites, giving the study access to distinct patient populations for a more inclusive
dataset as well as a larger geographic footprint that should speed adoption once the treatment is approved.
Finally, we will construct a retrospective control cohort of SBS cases that were medically managed; comparing
outcomes for the treated cohort to those of controls will help demonstrate the benefit of the XL1 device.
Thus, this study will directly support and accelerate Eclipse's efforts to secure XL1 regulatory approval via
the HDE pathway, the final step in bringing this ground-breaking, curative treatment for SBS to patients.

Public health relevance
PROJECT NARRATIVE Short Bowel Syndrome (SBS) is a rare and chronic condition where patients lack enough functioning small intestine to absorb sufficient nutrition from food. Eclipse Regenesis, Inc. is developing a novel medical device– –currently in first-in-human safety trials––that induces the intestine to grow, potentially offering a curative solution for this devastating condition. The proposed study will support the probable benefit phase of the trial to secure approval as a Humanitarian Use Device, the final step to bringing the XL1 device to the clinic.